Imaging structure and function

IMAGING STRUCTURE AND FUNCTION CORE SUMMARY Imaging technologies such as confocal microscopy, multiphoton microscopy and super- resolution imaging as well as optical coherence tomography have transformed the ability of scientists to observe structural and functional changes in the visual system, in vivo and ex vivo, in both health and disease. The overarching goal of the imaging core is to transform the ability of vision scientists to use these critical technologies by providing access to and training on the newest imaging modalities, and transferring novel approaches between groups to facilitate innovation in research and collaboration across vision research disciplines. This goal will be achieved through supporting (1) access to new confocal and OCT/in vivo fluorescence microscopes as well as custom adaptive optics imaging ophthalmoscopes that will be made available through the Ophthalmology Department, (2) access to advanced imaging modalities available through various Stanford Microscopy Facilities, and (3) application and dissemination of customized in vivo imaging approaches and systems developed by investigators in the vision research center.

Public health relevance
IMAGING STRUCTURE AND FUNCTION CORE RELEVANCE Modern imaging technologies are central to vision research, allowing scientists to discover fundamental new principles into the mechanistic underpinnings of visual system development, function and disease. This core will support and expand the use of these technologies by vision center investigators.